Dissecting the role of vaccine-promoted Th17 cells in protective immunity against tuberculosis

ABSTRACT
An effective vaccination strategy is urgently needed to combat tuberculosis (TB), but lack of knowledge on
protective immunity remains a major bottleneck for rational design, testing, and down selection of new
candidates. Although essential for host defense, Th1-produced IFNγ is not sufficient for vaccine protection and
there is growing consensus that novel immune responses, not induced by TB itself, may be needed for optimal
disease control. In recent years, Th17 cells have gained increasing attention as a target for vaccine optimization
due to their association with protection signals in both mice and non-human primates. However, their significance
in protective immunity against TB is still unresolved. As none of the existing vaccine candidates induce robust
Th17 responses, we developed the novel vaccine candidate H107e/CAF® to maximize Th1/Th17 induction
across species. In 2024, this entered phase Ia/Ib trials as the first subunit vaccine with these properties. However,
other than safety and magnitude of the immune responses, which historically does not correlate with protection,
there are no validated biomarkers for vaccine pipeline decision-making on topics including dose optimization and
progression to efficacy trials. With preliminary data suggesting that Th17 cells account for ≥50% of the
H107e/CAF®-induced protection in mice, the goal of this proposal is to determine the role of vaccine-induced
Th17 cells in local immunity and pathology as well as to identify and validate related signatures in human
samples. Displaying a range of unique characteristics, Th17 cells could play several non-redundant roles and
we will focus on three separate leads, guided by preliminary data. In Aim 1, we will determine the contribution of
vaccine-Th17 cells in early neutrophil recruitment and test the hypothesis that the earliest wave of neutrophils
mediate trafficking of bacteria to the draining lymph node to accelerate T cell priming. We will also examine how
Th17 cells are regulated in vivo at later time points and test whether vaccine-induced IFNγ responses down
regulate late neutrophils to prevent tissue destruction. In Aim 2, we will investigate whether accelerated formation
of inducible bronchus associated lymphoid tissue (iBALT) is unique to H107e/CAF® compared to other clinically
relevant vaccines and determine the role of vaccine-induced Th17 cells iBALT formation. We will also assess
the significance of iBALT in H107e/CAF®-mediated protection with the hypothesis that iBALT mediates efficient
trafficking and localization of protective immune cells in TB lesions. In Aim 3, we test the hypothesize that
vaccine-promoted Th17 cells display IFNγ-independent protective effector functions and define a set of
biomarkers that tracks with Th17-protection and regulation across Aims 1-3. These are validated in banked NHP
and human H107e/CAF® clinical trial samples. Together, this project will benefit from utilizing a vaccine in clinical
trials to elucidate the fundamental role of Th17 cells in vaccine-induced immunity to TB. With complementary
expertise in basic science and translational vaccinology in our labs, we have designed these studies to identify
biomarkers that will inform development of new TB vaccines and support the clinical testing of H107e/CAF®.

Public health relevance
Project Narrative Protective immunity to tuberculosis (TB) remains incompletely understood and this project investigates how Th17 cells induced by vaccination uniquely contribute to improve disease control. Findings will be translated into defined biomarkers to support development and testing of new vaccine candidates against tuberculosis.